1/4-The INTEGRATE Study: Evaluating INTEGRATEd Care to Improve Biopsychosocial Outcomes of Early Liver Transplantation for Alcohol-Associated Liver Disease

Alcohol-associated liver disease (ALD), which includes alcohol-associated cirrhosis (AAC) and alcohol-associated hepatitis (AH), is now the leading indication for liver transplant (LT) in the US. Early LT (eLT), defined as LT evaluation with <6 months of alcohol abstinence, is associated with acceptable outcomes for AH in retrospective studies. However, prospective, multi-center data including biopsychosocial factors on eLT for all advanced ALD are lacking. It is known that alcohol cessation is the most important factor influencing survival in ALD, and integrated alcohol use disorder (AUD)/ALD care is critical to help patients achieve abstinence, yet the degree of care integration and how this influences post-LT outcomes has not been systematically studied. Knowledge gaps in eLT for ALD include: a) limited data on who gets referred for eLT and referral barriers; b) lack of standardized biopsychosocial measures and outcomes; and c) minimal stakeholder involvement beyond LT providers. There is an urgent need to (1) define factors influencing eLT referral, (2) develop risk prediction models of key patient-centered outcomes, (3) incorporate validated biopsychosocial measures into models, and (4) evaluate the impact of integrated care on outcomes following eLT. For example, The INTEGRATE collaborative, comprised of multidisciplinary clinicians and researchers from the University of Texas Southwestern Medical Center, Henry Ford Health, University of Miami, and Columbia University-Weill Cornell Medicine, is ideally positioned to address these urgent research needs. Collectively, we have developed a distinctive investigator team which varies in: (1) career stage, (2) clinical and methodological expertise in ALD, AUD, LT, behavioral research, risk modeling, data harmonization, causal inference, and mixed-methods research, and (3) has a documented track record of NIH funding in LT access, organ allocation, LT and healthcare outcomes, and NIAAA funding in ALD/AUD. Our large volume transplant centers with established protocols for eLT for ALD applied will facilitate the following aims: 1) characterize and develop risk prediction models for transplant-free survival among those with limited access to LT to define those in greatest need of eLT referral and listing; 2) evaluate barriers and facilitators to referral for eLT in ALD; 3) apply causal inference approaches to observational data to evaluate biopsychosocial factors and develop risk models predictive of outcomes at key timepoints in eLT for ALD; 4) define stakeholder perceptions and preferences for selection and outcomes in eLT for ALD; and 5) evaluate how integrated care processes influence outcomes in eLT for ALD. At the conclusion of this work, we will have collaboratively: (1) defined factors for referral and waitlisting for eLT in ALD (selection), (2) identified which biopsychosocial factors are causally related and predictive of outcomes most important to stakeholders (outcomes) and (3) determined how integrated care influences stakeholder-relevant outcomes in eLT for ALD (management).

Public health relevance
Early liver transplantation (eLT), defined as LT evaluation with <6 months of alcohol abstinence, is associated with acceptable outcomes for patients with severe alcohol-associated liver disease (ALD) in retrospective studies. However, prospective, multi-center data including biopsychosocial factors on eLT for all patients is lacking. The INTEGRATE collaborative is a balanced investigative team that seeks to: 1) define factors influencing referral and waitlisting for eLT in ALD (selection); 2) identify which biopsychosocial factors are causally related and predictive of outcomes most important to stakeholders (outcomes); and 3) determine how integrated care among the healthcare team influences stakeholder- relevant outcomes in eLT for ALD (management)